In vivo modelling and therapy development for stathmin-2 loss in TDP-43 proteinopathies

PROJECT SUMMARY
TDP-43 proteinopathies represent a set of neurological disorders characterized by relocalization of the RNA-
binding protein TDP-43 from its native nuclear compartment to the cytoplasm where it accumulates into
aggregates. TDP-43 pathology is found in more than 95% of patients with amyotrophic lateral sclerosis (ALS),
approximately half of frontotemporal dementia (FTD) cases, and more than 30% of Alzheimer’s disease patients.
TDP-43 is involved in fundamental RNA processing activities and binds thousands of transcripts to regulate their
expression, splicing and transport. We and others have recently identified a critical role for TDP-43 in regulating
the expression of the neuronal growth-associated factor stathmin-2, a tubulin-binding protein involved in axon
outgrowth and regeneration. TDP-43 disruption induces truncation (by aberrant splicing and premature
polyadenylation) of stathmin-2 pre-mRNA, thereby silencing stathmin-2 when TDP-43 nuclear levels fall.
Stathmin-2 is suppressed in affected neurons from the vast majority of ALS/FTD patients, and the neuronal
regeneration capacity of iPSC-derived motor neurons with TDP-43 depletion can be rescued by increasing levels
of STMN2. Notably, while stathmin-2 is the human mRNA most affected by reduction in TDP-43, the stahmin-2
pre-mRNA is neither bound nor regulated by TDP-43 in rodents, a major caveat for animal modeling of TDP-43
proteinopathies. Here we propose to use newly generated mouse models to determine whether inactivated (Aim
1) or humanized stathmin-2 (Aim 2) alleles synergize with TDP-43, progranulin, or C9ORF72 ALS/FTD
mutations to drive motor neuron or cognitive disease. While evidence supports that stathmin-2 is essential for
axonal regeneration, the contribution of stathmin-2 loss in neurodegeneration remains to be determined. We
propose an ambitious program to establish the impact of in vivo stathmin-2 reduction in TDP-43 proteinopathies.
Mouse models generated in this project will recapitulate a major molecular alteration associated with TDP-43
proteinopathy and represent an important platform for therapeutic development in ALS/FTD. In addition,
recognizing that restoration of stathmin-2 level is an attractive strategy with broad implications in
neurodegenerative diseases, we will test the therapeutic potential of antisense oligonucleotides (ASO) that
prevent aberrant splicing of Stmn2 (Aim 3). This collaborative effort has the potential to uncover new insights on
the contribution of stathmin-2 loss in neurodegeneration, to generate new preclinical models, and to develop a
novel therapeutic strategy for ALS and FTD.

Public health relevance
PROJECT NARRATIVE Loss of stathmin-2 has emerged as a major pathological hallmark in several neurodegenerative conditions including amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD). Using newly generated mouse models, we will test the impact of stathmin-2 loss on ALS and FTD and develop a therapeutic approach for sporadic and familial ALS/FTD based on antisense oligonucleotides (ASO)-mediated restoration of stathmin-2 level.